Non-cleaved Electro-Mechanical Expansion (NEME) technology for super-resolution imaging of biological samples with conventional optical microscopes

Abstract Understanding the nanoscale organizations of biomolecules in complex biological systems such as the brain, can not only provide fundamental biological insights but also help in the discovery of new targets and technologies for treating diseases. Optical microscopy provides a convenient way for imaging biological samples using readily available dyes/antibodies. However, the spatial resolution of conventional optical microscopes is limited to 300 nm due to the diffraction of light waves. On the other hand, existing super-resolution optical techniques, face challenges in scalability to thick tissues and require extremely expensive hardware, which limits their application. Recently discovered expansion microscopy (ExM), which is based on physically expanding the sample (embedded in a swellable gel) by about 4.5 x and thus, achieving an effective resolution of 70 nm, is scalable and compatible with conventional optical hardware. But, its resolution of 70 nm is not sufficient for observing subcellular structures. Though the resolution can be improved through iterated ExM (iExM), it results in low biomolecular yield as it requires transfer of biomolecules from one gel to another, with the cleaving of the first gel. The proposed work aims to develop a technology for expansion, where gel cleaving or transfer of biomolecules is not required, resulting in high biomolecular yields. This technology utilizes both electrostatic and mechanical forces for expansion to achieve high expansion factors (20x to 100x), thus leading to 300 / 20 ? 15 nm to 300 / 100 ? 3 nm resolution. This technology, which I termed non-cleaved electro-mechanical expansion (NEME) is different from previous expansion technologies which utilizes only electrostatic forces for expansion. The mentored phase of the proposed work will involve the development and characterization of the NEME technology while in the independent phase, NEME will be extended for imaging of dense protein complexes as well as RNA and DNA. NEME technology can lead to super-resolution imaging without any specialized or expensive hardware and can also provide high biomolecular yields and scalability to thick tissues. Thus, it can greatly benefit simultaneous characterization of super-fine biomolecular structures and large 3D biological systems.

Public health relevance
PROJECT NARRATIVE The proposed work will develop the technology that will enable super-resolution imaging without the need for any specialized or expensive hardware. This technology can greatly benefit simultaneous characterization of super-fine biomolecular structures and large 3D biological systems, which can provide fundamental biological insights and also, enable the discovery of new targets and technologies for treating diseases.